Sleep health of preschool children in Bangladesh: predictors, role on executive function and obesity, and sleep promotion intervention

This is a resubmission for Fogarty International Center K01, International Research Scientist Development
Award for Dr. Ayesha Sania, at the Department of Psychiatry at Columbia University Medical Center. Dr.
Sania, an epidemiologist and physician by training, has a strong track record of studying early life risk factors
of child physical growth and neurodevelopment in low- and middle-income countries (LMICs) using secondary
data. Through this IRSDA, Dr. Sania will gain (1) experience in primary data collection in Bangladesh, (2)
knowledge and skills to study sleep health and executive function (EF), (3) training in advanced statistical
methods to study role of sleep health on child outcomes and (4) training in community-based participatory
research approaches for intervention adaptation to support her transition to research independence. The
scientific premise of the proposal is based on the growing recognition of poor sleep health among children as a
public health concern worldwide. Based on preliminary data, an estimated 40% of preschool children (2–5-
years) in urban Bangladesh sleep less than the duration recommended by the WHO (10-13 hour/day). Sleep
impacts a range of physical and neurodevelopmental outcomes including EF and obesity risk, which are public
health priorities in LMICs. Despite the

Public health relevance
This K01 International Research Scientist Development Award seeks to provide the applicant experience in primary data collection in Bangladesh, knowledge, and skills in the measurement of sleep health and executive function, advanced statistical methods to examine socio-ecologic determinants of sleep, and community-based participatory research approaches for intervention adaptation to support the applicant's transition to research independence. Through the training embedded in this award, the applicant will develop the skills and expertise necessary to study sleep health of preschool children as a modifiable behavior to improve executive function and reduce the risk of childhood obesity. A feasible and culturally appropriate sleep health promotion intervention adapted during this training has the potential to improve long-term physical and developmental outcomes for millions of children in low- and middle-income countries.